Improving Anxiety Treatment Engagement and Effectiveness in Primary Care-Mental Health Integration: Multi-site Hybrid I RCT of a Brief Veteran-Centered Anxiety Intervention

Background: Many Veterans experience impairing symptoms of anxiety and seek treatment in primary care,
yet anxiety is highly undertreated in this setting. Primary Care-Mental Health Integration (PCMHI), in which
mental health clinicians embedded in primary care provide brief treatment, affords an opportunity to address
this treatment gap. However, behavioral interventions that are compatible with the brief PCMHI treatment
format and able to accommodate a wide range of anxiety presentations are needed. Accordingly, Veterans
Anxiety Skills Training (VAST) was designed to be evidence-based, transdiagnostic, feasible for PCMHI, and
Veteran-centered. VAST comprises empirically-supported cognitive-behavioral therapy (CBT) techniques
adapted into a manualized modular intervention specifically designed for delivery in PCMHI. As VAST is being
piloted at a single site with study therapists, the next scientific step is a multi-site randomized controlled trial
(RCT) to evaluate its effectiveness using PCMHI providers in routine care. Significance/Impact: This study
addresses Veteran care priorities of mental health and suicide prevention, MISSION Act priorities of increasing
access to care and improving patient satisfaction with Veterans Health Administration (VHA) care, and Health
Services Research and Development (HSR&D) focus areas of quality, effectiveness, and efficiency as well as
implementation science research methods. Improving anxiety treatment in PCMHI will address a major gap in
VHA treatment options, given the high prevalence of anxiety in primary care, tendency for patients with anxiety
to seek treatment in primary care rather than specialty mental health settings, and absence of Evidence-Based
Psychotherapy (EBP) protocols addressing non-trauma related anxiety. Innovation: Modular (vs. standard)
intervention designs offer advantages in efficiency, patient and provider satisfaction, efficacy, effectiveness,
implementation, and sustainability. Other innovative aspects include the transdiagnostic approach and
examination of fidelity to inform future implementation. Specific Aims: The specific aims are to: (1) Compare
patient clinical outcomes for VAST vs. PCMHI usual care between baseline and 16 weeks (post) in a multi-site
RCT in which PCMHI providers deliver VAST, and examine whether treatment gains are more likely to be
maintained for VAST vs. PCMHI usual care at 28 weeks (follow-up); (2) For participants assigned to receive
VAST, explore patient-level predictors of (a) early (8 weeks) and (b) overall (16 weeks) treatment response;
and (3) Conduct a mixed-methods process evaluation of VAST implementation to examine rates of, barriers to,
and facilitators of achieving and sustaining high-fidelity intervention delivery. Methodology: In this multi-site,
hybrid type I effectiveness-implementation RCT, 178 adult Veterans with elevated anxiety symptoms will be
recruited from primary care at two VHA sites. PCMHI providers will be randomized to deliver either VAST or
usual care (routine PCMHI care, meaning whatever care the provider deems appropriate), and participants will
be randomized to condition. VAST (up to six biweekly 30-minute sessions) consists of a standard initial and
final session as well as up to 4 CBT skills-based modules. The primary outcome (Overall Anxiety Severity and
Impairment Scale) and secondary outcomes (anxiety and depressive symptom severity, functioning, quality of
life, suicidality) will be assessed at baseline, 4, 8, 12, 16 (post) and 28 weeks (follow-up). Multi-level modeling
will be used to evaluate the hypothesis that patient clinical outcomes will improve more from baseline to 16
weeks for participants receiving VAST compared to PCMHI usual care. Multivariate logistic regression will be
used to explore predictors of early (8 weeks) and overall (16 weeks) VAST treatment response. A mixed-
methods process evaluation will examine the proportion of PCMHI providers who achieve and sustain high-
fidelity VAST delivery as well as barriers to and facilitators of high-fidelity delivery. Implementation/Next
Steps: VAST will be disseminated to VHA PCMHI leadership and providers nationwide using several
strategies, and a follow-up hybrid III trial will facilitate formal implementation in VHA PCMHI.

Public health relevance
Many Veterans experience impairing symptoms of anxiety and seek treatment in the primary care setting, yet behavioral (non-medication) anxiety treatment options in primary care are quite limited. Primary Care-Mental Health Integration (PCMHI), in which mental health clinicians embedded in primary care provide behavioral treatment, can help bridge this treatment gap, but brief anxiety interventions that are compatible with PCMHI practice are needed. This proposal evaluates a brief anxiety intervention that is evidence-based, transdiagnostic (applicable to a wide range of anxiety symptoms), feasible for delivery in PCMHI (brief sessions), and Veteran-centered (tailored to Veterans and personalized to individual patients). This research addresses a major gap in VHA treatment options for anxiety and will facilitate high quality Veteran healthcare that improves clinical outcomes and patient experience. The intervention’s innovative modular design, in which Veterans collaboratively select which coping skills to learn, improves treatment engagement and acceptability.